Biostatistics and Data Management Core

PROJECT SUMMARY / ABSTRACT: Biostatistics and Data Management Core
The Biostatistics and Data Management Core will provide support for the three Main Projects, Pilot Projects and
trainees. The Core has a team of experienced biostatisticians and other quantitative experts with a wide diversity
of skills, including innovative statistical analysis, REDCAP database design and management, clinical trials
monitoring and reporting and bioinformatics. The Core has developed a large infrastructure in the previous
funding period (Penn State TCORS; P50 DA036107) and has worked closely with each of the project leaders.
The Core will be an integral part of the whole Project. Its members will participate in regular project meetings
and will provide timely and high-quality service by welcoming walk-in discussion and by quick turnaround in data
analysis (1-3 workdays). The Core Director will also present progress reports at each of the External Advisory
Board meetings. The core will take steps to enhance the rigor and reproducibility of the research, using the
REDCAP database management system to ensure data accuracy, providing weekly reports of study progress,
and ensuring that have a set of clearly defined scientific questions before data collection and analysis begins,
using best-practice and transparent statistical methods. Overall, the three Main Projects, Pilot Projects and
Career Development activities test hypotheses about tobacco products and their impact on addiction, toxicity
and health effects. The biostatistics Core staff have become well versed in tobacco research, have co-authored
TCORS publications, and provide advice on statistical approaches as they relate to tobacco-specific issues.
They will participate in the Career Enhancement Training Program, including mentoring of students and serving
as class instructors in the TCORS-accredited courses. Additionally, they will be statistical consultants to the pilot
projects, including providing assistance with power calculations, design issues and statistical analyses of results.